Profiling the specificity of SPI1 and SPIB activity for drug discovery

PROJECT SUMMARY/ABSTRACT: Profiling the specificity of SPI1 and SPIB activity for drug discovery
Diseases involving cells of hematopoietic origin are extensively involved in rare diseases, defined as affecting
200,000 or fewer people in the U.S. SPI1 (PU.1) and SPIB (Spi-B) are two master transcription factors in the
hematopoietic system that are deregulated in a broad spectrum of rare diseases, including: leukemias,
lymphomas, myeloma, histiocytic sarcomas, rheumatic diseases, systemic fibroses, inborn errors of immunity,
and osteopetrosis. The broad relevance of PU.1 and Spi-B to rare diseases makes them particularly attractive
therapeutic targets.
As members of the Class III ETS superfamily of transcription factors, PU.1 and Spi-B are structurally
homologous proteins despite their functional and pathophysiologic differentiation. As progress by our group and
others is being made in asserting pharmacologic control over PU.1, it is apt to consider strategies by which
structurally conserved transcription factors may be distinguished in drug discovery. To this end, we have
discovered that low-MW ligands can modulate PU.1 binding efficiently outside the orthosteric protein/DNA
interface. Such allosteric modulation opens the possibility that a transcription factor may be selected with a ligand
at a non-orthosteric site that is critical for cooperative DNA-binding with or recruitment of a distinct protein binding
partner. In this novel hypothesis, the targeted unit is a more precisely specified combinatorial complex, rather
than a single constituent that engages DNA in a conserved fashion.
From the literature, partnerships with Oct-2 (POU2F2) and interferon regulatory factor IRF4/8 (IRF4/IRF8) are
known from ChIP-Seq studies to attend PU.1- and SpiB-specific occupancy in the genome. Functionally,
PU.1/Oct-2 and Spi-B/IRF partnerships are associated with rare diseases such as the auto-immune disorders
mediated by microRNA-155 (e.g., idiopathic arthritis) and Williams syndrome (a rare congenital multi-system
disorder), respectively. The molecular specification of these disease-relevant complexes by the two structurally
homologous ETS factors are currently not understood. Moreover, we lack experimental tools capable of
distinguishing PU.1- and SpiB-selective binding in cells. This pilot project is aimed at addressing these gaps in
order to test the novel hypothesis that PU.1 and Spi-B can be selectively targeted as the PU.1/Oct-2 and Spi-
B/IRF4(8) complexes respectively. We propose to characterize the structure, affinity, and cooperative properties
of these complexes, and develop a reporter platform capable of detecting selective PU.1 and Spi-B activity in
cells. The results will support future proposals aimed at discovering new compounds that target PU.1 and Spi-B
with specificity, including library screening for ligands to serve as probes or therapeutic leads in rare diseases.
The prospect of effectively targeting PU.1 and Spi-B would impact a broad spectrum of rare diseases and
presents a strong value proposition over single-indication targets for this RFA.

Public health relevance
PROJECT NARRATIVE Two master regulators of gene expression, SPI1 (PU.1) and SPIB (Spi-B), are extensively involved in rare diseases, including hematologic cancers, soft-tissue tumors, auto-immune and immunodeficiency disorders. Currently, there is no drug or other therapeutic strategy to differentiate SPI1 or SPIB which play different roles in these diseases. The proposed pilot studies will result in preliminary data and a set of gene-based molecular tools that will facilitate future discovery of compounds against SPI1 or SPIB with specificity.